Simulation-Based Caregiving Skills Training for Family Members of High Grade Glioma Patients

PROJECT SUMMARY/ABSTRACT
Patients with brain tumors experience more debilitating sequelae compared to other cancer patients and thus,
often dependent on their family members for care and support early on in the disease course. While caregiving-
related activities are taxing in general, family caregivers of brain tumor patients face unique challenges related
to patient cognitive decline, neurological and motor deficits, and personality changes due to the disease process
and treatment. With the typical rapid disease progression and subsequent patient functional decline, caregivers
increasingly assist patients with activities of daily living (e.g., bathing, feeding, dressing) as well as coordination
of care, symptom and medication management, and decision-making. Essentially, caregivers provide basic
nursing care without skill-based training. Moreover, despite clear evidence of high caregiver distress and burden,
which may impact their ability to care for the patient, caregivers report that their support needs are often
unattended to by multi-disciplinary oncology teams. In fact, the neuro-oncology literature generally lacks
evidence-based supportive care interventions for this vulnerable population. To address these critical knowledge
gaps, we propose to pilot-test a novel simulation-based caregiving skills intervention to target the unique needs
of caregivers. Given interdependence in distress and quality of life in families coping with cancer, we expect that
this caregiver-focused intervention will improve not only caregiver but also patient outcomes. Using a
randomized controlled trial (RCT) design, patient-caregiver dyads will be randomized to the intervention or a
waitlist control (WLC) arm. The intervention content will be delivered via three modes: education materials (i.e.,
workbook and video), two simulation-based caregiving skills training sessions, and two psychoeducation
sessions addressing coping with caregiving-related role changes. The four manualized sessions will be nurse-
led and tailored to the needs of the family’s current situation using a needs assessment driven approach. Patients
and caregivers will complete self-report measures at baseline (prior to randomization) and 6 and 12 weeks later.
We will assess patient and caregiver psychological symptoms, caregiver efficacy and role adjustment, and
patient cancer-related symptoms as intervention outcomes. Because psychological distress in caregivers is
associated with increased preventable healthcare utilization, we will abstract emergency department visits,
hospital admissions, and unplanned oncologist visits from patients’ medical records. We will integrate qualitative
accounts of the caregivers’ experiences with the multi-model intervention components. Feasibility data regarding
consent, retention, adherence, and program evaluation will be recorded. The proposed work will provide rich
pilot data that will inform a subsequent larger trial for formal efficacy testing of this innovative intervention seeking
to improve cancer-related burden in this vulnerable yet understudied patient-caregiver population.

Public health relevance
Project Narrative Family caregivers of patients with a primary brain tumor experience a high caregiving load including assistance with activities of daily living without any formal training. It is not surprising that this vulnerable caregiver population reports high levels of distress along with numerous caregiving-related concerns, which may compromise their ability to provide quality care. This project will examine the feasibility and initial evidence for efficacy of a caregiving skills intervention aiming to improve caregiver and patient psychological health; caregiving efficacy and role adjustment; and reduce patient cancer-related symptoms and healthcare utilization.